Intestinal NOD2 and the microbiota enhance Coxsackievirus B3 pathogenesis

PROJECT SUMMARY
Group B coxsackieviruses (CVB) are in the genus Enterovirus and Family Picornaviridae. CVBs are spread by
fecal-oral transmission and can cause diseases including intestinal inflammation, pancreatitis, myocarditis and
central nervous system diseases. Sensing of CVB3 RNA by melanoma differentiation-associated gene (MDA5)
induces a Type 1 Interferon (T1IFN) response that is critical for reducing viral replication and dissemination within
cells and the host. The pattern recognition receptor (PRR) Nucleotide Oligomerization Domain protein 2 (NOD2),
which is critical for intestinal immunity, is classically known to detect bacterial peptidoglycan. Once stimulated,
NOD2 requires RIP2 kinase (RIP2K) to activate NF-kB leading to a pro-inflammatory response. More recent data
has demonstrated that NOD2 can also function as a cytoplasmic viral PRR by activating the production of T1IFNs
in response to Influenza A virus. Interestingly, NOD2 has been implicated in a proviral role in CVB3-induced
myocarditis, however, the underlying mechanism is not well understood. Because NOD2 is especially important
in regulating the intestinal microbiota and maintaining intestinal immune homeostasis and CVB3 is an enteric
virus that initially infects the intestinal tract leading to virus dissemination to other tissues, we sought to determine
whether NOD2 expressed intestinal epithelial cells (IECs) would impact CVB3 infection. We observed that IEC
NOD2 exacerbates CVB3 pathogenesis and fecal shedding in mice that were infected with CVB3. Additionally,
we observed that the intestinal microbiota is required for CVB3 pathogenesis, suggesting that the microbiota
may influence CVB3 infection by modulating host immunity through IEC NOD2. Furthermore, we demonstrate
that IECs deficient for NOD2 have increased T1IFNs and Interferon Stimulated Genes (ISG) expression that
limits CVB3 replication. CVB3 replication and ISG expression was rescued when IFIH1 (MDA5) expression was
reduced with small interfering RNAs (siRNAs). In addition, NOD2-/- IECs have impaired mitochondrial health
measured by increased ROS production and loss of mitochondrial membrane potential. In this proposal we will
test our hypothesis that microbiota activation of IEC NOD2 induces mitophagy which blunts T1IFN
responses and MDA5 expression resulting in exacerbated CVB3-induced pathogenesis. We will test key
aspects of our hypothesis using the logical and innovative approach outlined in the following specific aims. Aim
1. Examine if CVB3 infection alters the microbiome causing dysbiosis that activates IEC NOD2 to
contribute to CVB3-induced pathogenesis. Here we will define whether IEC NOD2 and the microbiota are
initiators of CVB3-induced pathogenesis. Aim 2. Determine if NOD2/RIP2K expressed in IECs induces
mitophagy to inhibit MDA5 activation and T1IFN responses. We will test whether NOD2/RIP2K signaling
contributes to effective mitophagy leading to decreased MDA5-mediated antiviral responses and susceptibility
to CVB3 infection. Characterizing and understanding the mechanisms of NOD2-dependent proviral responses
are innovative new concepts that would markedly influence the current beliefs of NOD2 biology.

Public health relevance
PROJECT NARRATIVE Coxsackievirus B3 (CVB3) is an enteric virus that infects many organs including the intestine, pancreas, heart and central nervous system. CVB3 viral RNA is sensed by the pattern recognition receptor MDA5 leading to a Type 1 Interferon response that is critical for reducing viral replication and dissemination within cells and the host. The innate immune sensor NOD2, however, promotes CVB3 infections, and in this proposal we aim to understand and characterize a novel pathogenic role of intestinal NOD2 by inhibiting MDA5-induced antiviral responses.